Two-photon fluorescence lifetime imaging microscopy utilizing the space-time duality

PROJECT SUMMARY
Fluorescence lifetime imaging microscopy (FLIM) is a type of fluorescence imaging technologies that is
gaining popularity in biomedicine because it delivers the most direct insight into the molecular conformation and
the biological environment of a fluorophore. FLIM has been applied to provide insights into the cellular
metabolism, protein-protein interactions, and biological environment monitoring of temperature, viscosity, pH,
and ion concentration. Despite the wealth of information provided by the FLIM, its widespread application is
currently limited by the low imaging speed. The FLIM imaging speed is a complex function of many factors, with
shot noise by the photon counting statistics being the fundamental limit. This limitation is especially dominant for
fluorophores with lifetime shorter than the FLIM instrument response function (IRF) when deconvolution is
necessary to accurately determine the fluorescence lifetime. Thus, to fundamentally enhance the FLIM imaging
speed, either an increase of the maximum photon counting rate or a reduction of the FLIM IRF is necessary.
Time-domain FLIM with high photon efficiency can be implemented with either time-correlated single-photon
counting (TCSPC) or photon counting streak camera (PCSC). The maximum photon counting rate of state-of-
the-art time-domain FLIM is 1-10 mega counts per second (Mcps), limited by the pile up effect in TCSPC-FLIM
and the readout nonlinearity and crosstalk in PCSC-FLIM. TCSPC-FLIM generally has a 100-ps IRF, unless
superconducting nanowire single-photon detectors that require cryogenic cooling are implemented to reach the
picosecond regime. On the other hand, PCSC-FLIM can achieve the picosecond IRF at room temperature, but
complex streaking and detection optoelectronics are required. Using PCSC-FLIM, a recent study on Alzheimer
mouse brain tissue has found a new 30-ps lifetime component, critical for separating Alzheimer disease from
normal brain tissue, of nicotinamide adenine dinucleotide hydrate (NADH). Without the 10-ps IRF of PCSC-FLIM,
such fast fluorescence decay could not have been observed within a reasonable amount of time. Similarly, a
short IRF will benefit the study of short-lived non-lipofuscin autofluorophores (30-70 ps) that will lead to a better
understanding of the fundus autofluorescence diagnosis and may provide relevant retina information for the early
detection of age-related macular degeneration and neurodegenerative diseases.
This proposal will develop a potentially transformative FLIM system, photon-streaking FLIM (PS-FLIM), that
addresses the imaging speed challenge by simultaneously reducing the IRF and increasing the maximum photon
counting rate. A new concept of photon streaking, based on the principle of space-time duality, will be
implemented to achieve 5-ps IRF and 840 Mcps in a compact and lightweight platform. Two-photon excitation
will be utilized to increase the imaging depth and reduce the phototoxicity. Finally, machine learning framework
will be incorporated to accelerate the FLIM data analysis.

Public health relevance
PROJECT NARRATIVE Fluorescence lifetime imaging microscopy (FLIM) is a type of fluorescence imaging technologies that is gaining popularity in biomedicine because it delivers the most direct insight into the molecular conformation and the biological environment of a fluorophore. This project will address the key imaging speed challenge that limits FLIM’s widespread application by reducing the instrument response function and increasing the maximum photon counting rate. In addition, two-photon excitation will be utilized to reduce the phototoxicity and machine learning framework will be developed to accelerate the FLIM data analysis.